Administrative Core

Abstract/Project Summary – ADMINISTRATIVE CORE
The vision of the Center for Perioperative Mental Health is to incorporate mental health as a key component of
perioperative care. With this vision in mind, the Administrative Core’s mission will be to develop strategies and
tactics to inform both the overarching directions of the Center and specific important decisions. The
Administrative Core will coordinate the various components of the Center to ensure progress and impact. The
Core will provide intellectual and logistical support to the investigators and to the extended members of the
research team. The Core’s leaders will ensure that all the projects are complementary and synergize with each
other and with the cores of the Center. This will apply both to the initial three R34 trials as well as to the annual
R03 pilot projects. The Center will be integrated into institutional training programs, including several
departments’ T32 programs, as well as training programs offered by the Institute of Clinical and Translational
Sciences, the Goldfarb School of Nursing, and the Implementation Research Institute. The Administrative Core
will have additional key roles, including auditing progress of projects, collaborating with investigators when
challenges arise, planning future projects that are consistent with the mission of the Center, widely sharing
knowledge generated by the Center’s activities, and disseminating the evidence emerging from the Center into
other institutions in the country. In order to achieve these goals, the Administrative Core of the Center for
Perioperative will organize and lead the following activities:
1) Bring together a transdisciplinary group of experts to develop the Center and lead its efforts.
2) Coordinate and oversee the various components of the Center.
3) Ensure that the appropriate support is delivered where and when needed.
4) Provide an infrastructure and environment to support training of investigators within the Center, and
integrate with institutional training programs.
5) Solicit proposals for annual R03 pilot projects and provide thematic guidance for applications according to
the perceived priorities of the Center.
6) Arrange annual assessment of the Center’s activities and impact, and ensure auditing of the R34 trials and
the R03 pilots.
7) Based on assessments of progress and needs, provide leadership in planning future priorities and
directions for the Center, and engage our Stakeholder Advisory Board in providing input and direction.
8) Facilitate dissemination of the evidence synthesized by the Center and promote implementation of
evidence regarding perioperative mental health both within the Center and more broadly in different
perioperative environments.

Public health relevance
Project Narrative – ADMINISTRATIVE CORE The Administrative Core for the Center of Perioperative Mental Health will develop strategies and tactics to inform both the overarching directions of the Center as well as specific important decisions. The Administrative Core will coordinate the various components of the Center to ensure progress and impact. This Core will provide intellectual and logistical support to the investigators and to the extended members of the research team. The Core’s leaders will ensure that all the projects are complementary and synergize with each other and with the cores of the Center.